Molecular Architecture and Function of synaptic AMPA receptor complexes

Abstract:
Synaptic transmission is a key process for communication between neuronal cells. Despite
numerous advances, our understanding of the molecular details of synaptic transmission remains
incomplete. Deciphering the molecular details behind synaptic transmission could potentially lead
to the development of strategies for treatment of uncurable neurological disorders. In mammalian
brain, communication through neurotransmitter glutamate is the most common. From the several
types of receptors that are activated by glutamate, AMPARs (α-amino-3-hydroxy-5-methyl-4-
isoxazolepropionic receptors) stand out because they interact with numerous regulatory proteins
that affect AMPARs function. In the proposed experiments, we aim to uncover mechanistic details
of inter-neuronal AMPAR-mediated communication. We present a set of experiments and
advancements that will lead to high-resolution 3D structural views of AMPAR-based protein
complexes with regulatory proteins in their most physiologically relevant conformation. By
leveraging state-of-art custom biochemical, analytical, and biophysical approaches, we will obtain
the structure of physiologically relevant synaptic AMPAR complexes with regulatory proteins.
Next, we will gain functional insights into how those complexes are responsible for the
maintenance of the efficient synaptic transmission. We will validate our findings by a set of
biochemical approaches as well as by electrophysiological recordings coupled with in situ
cryoelectron tomography (cryo-ET) imaging of the synapses in fresh mouse brain slices. In
addition to several technological advancements that are potentially transferable to other transient
protein assemblies, our research will exert a major scientific impact on the AMPARs and synaptic
transmission fields. With the stellar team of collaborators, our expertise in the relevant fields,
carefully designed strategies, and awareness of potential pitfalls, we are highly confident in the
success of our studies aimed at understanding of synaptic transmission mechanisms. Ultimately,
we aim to utilize obtained structural information for the future structure-based therapeutics design
that will combat pathologies linked to altered synaptic transmission.

Public health relevance
Project Narrative: Communication between neurons is vital for healthy brain functioning, and its disruption is implicated in numerous neurological disorders and brain diseases. The objective of this project is to make a transformative leap forward in our understanding of intricate molecular mechanisms of neuronal communication by studying synaptic protein complexes. With custom biochemical, analytical, and biophysical approaches, we will delve into the details of how signal is transmitted between two neurons and pinpoint potential directions for future drug development against neurological disorders where neuronal communication is affected.